Center for Appalachian Research in Environmental Sciences-Integrated Health Sciences Facility Core (IHSFC)

PROJECT SUMMARY – Translational Research Support Core (TRSC)
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES)
Translational Research Support Core (TRSC) will facilitate translational research in
environmental health science (EHS), ranging from basic, clinical, exposure assessment, and
communication research, to support and sustain collaborative, multidisciplinary connections, and
academic-community partnerships. A key element of the TRSC is the formation of four EHS
translational research hubs: 1-Molecular Toxicology; 2-Clinical Research and Data Sciences; 3-
Community Exposure Assessment; and 4-Environmental Health Communication. Each hub will
provide content expertise, support, and access to EHS methodologies and services, and facilitate
project development across the translational research spectrum. The TRSC will support campuswide
integration and cross-Center
communication. The TRSC will build on our record of early success, refining our operational model
and targeting new partnerships among Center members while providing expert consultation,
translational research support, and team building strategies across the Center’s re-aligned science
themes: (a) Health Impacts of Waterborne Contaminants (WATER); (b) Health Impacts of Indoor
and Outdoor Airborne Contaminants (AIR); and (c) Emerging Environmental Health Threats
(EMERGING THREATS). Specifically, the TRSC aims to 1) provide access to EHS research services,
2) deliver EHS project support, and 3) enhance translational research partnerships. First, the TRSC
Research Support Portal will direct the flow of investigator requests to TRSC staff and relevant hub
leaders who will link Center members to the appropriate cores (e.g., Analytical
Chemistry Core for Environmental Sciences and Community Engagement Core) and resources
(e.g., data management and statistical analysis) for project facilitation. The Portal will facilitate
coordination, prioritization, tracking, and use of facility core services, Center-wide. Second, TRSC
hub leaders will provide EHS best practices workshops and training sessions in collaboration with
the Career Development Program. Third, we will establish Rapid Response Teams, comprised of
the hub leaders and other Center members, to promote research translation and partnerships,
enabling prompt responses to community identified EHS threats and new exposures. The IHSFC
will fulfill the need for a centralized and accessible core that supports multidirectional EHS
research activities within the Center, across UK campus, with community investigators,
and with other EHS Core Centers, providing timely consultation and support for an impactful
portfolio of EHS research projects, while fostering a highly collaborative institutional EHS culture.
The TRSC will expand expertise and services, enhancing the core’s central role in daily UK -CARES
operations, and provide the infrastructure to facilitate the progression and expansion of EHS from
fundamental questions into testing, clinical practice, and public health impact to improve public
health and clinical practice in environmental health.